Identifying the molecular target for macrophage activation by chlorpyrifos

Chronic exposure to low levels of organophosphate pesticides is associated with increased risk for asthma. We
have shown in experimental animals that low-level exposure activates lung macrophages to produce TNFa,
which in turn decreases expression and function of inhibitory M2 muscarinic receptors on airway
parasympathetic nerves, increasing the release of acetylcholine and potentiating reflex bronchoconstriction.
We hypothesize that molecular targets responsible for activation of macrophages by organophosphates
can be identified. To do so, we propose two specific aims:
Specific Aim #1: Use photocrosslinking and click chemistry to identify potential targets that chlorpyrifos
binds to on macrophages. We will synthesize chlorpyrifos photoaffinity ligand derivatives, and use these to
identify proteins in THP-1 macrophages that chlorpyrifos binds to. By competition with unmodified chlorpyrifos,
we will identify targets of specific binding by chlorpyrifos. We will also use CRISPR Cas9 gene editing to eliminate
the protein target in THP-1 cells, and test whether this prevents chlorpyrifos binding and activation by chlorpyrifos.
Results will be confirmed in experiments using human lung macrophages obtained by digestion of whole lungs.
Specific Aim #2: Use genome-wide CRISPR Cas9 gene editing to eliminate proteins in THP-1 cells, testing
the ability of deletions to block activation of THP-1 macrophages by chlorpyrifos. This approach will be
complementary to the photocrosslinking approach in Specific Aim #1, in that it will identify both chlorpyrifos-
binding proteins and also other proteins involved in signal transduction of chlorpyrifos activation. Comparing
results with binding data in Specific Aim #1 will differentiate among these groups of protein targets. We will also
test whether deleting the chlorpyrifos target protein decreases macrophage activation by the structurally related
organophosphates diazinon and parathion, which also cause hyperreactivity by activating macrophages. These
results will be confirmed in experiments using human lung macrophages obtained by digestion of whole lungs.
At the completion of this project, we will have identified the molecular target responsible for macrophage
activation by chlorpyrifos. Understanding this mechanism will suggest new therapeutic targets in pesticide
induced asthma. It will also be relevant to the central nervous system effects of low-level organophosphate
exposure, which are associated with activation of microglia, the resident macrophages of the brain. We will also
have established a new method for investigating interactions of organophosphates with target cells, which will
have broad applicability in studying the health effects of these ubiquitous environmental contaminants.

Public health relevance
Exposure to organophosphate pesticides carries significant health risks. In this project we will identify the cellular mechanisms for these health effects which will allow more rational approaches to prevention and treatment.